Reducing structural damage and adverse surgical events during cochlear implantation using an intraoperative sensing system

SUMMARY/ABSTRACT
Cochlear implants (CIs) restore hearing via direct electrical stimulation of the auditory nerve. Currently, the
surgeon must blindly thread an ultra-thin CI electrode array into the spiral-shaped cochlea, risking structural
damage that destroys residual acoustic hearing and impacts speech intelligibility outcomes. This loss of residual
hearing occurs in about 50% of operations, is identified by the FDA as an important implant-related risk, and
contributes to low CI adoption rates. Currently, only about 5% of eligible CI candidates receive a CI in the US.
Measurable characteristics of electrode insertion, including position and force, are linked to surgical outcomes
such as speech perception and structural damage, providing a pathway for ameliorating these risks. Presently,
these features are sensed manually & qualitatively by the surgeon during CI insertion, with adjustments in
technique depending heavily on subjective experience and surgeon dexterity. To address this significant clinical
gap, Advanced Optronics, Inc. (AO) is developing the “Sixth Sense” Surgical Guidance System, which uses a
sensor-enabled CI electrode to generate quantitative data for surgeons to utilize in real-time during electrode
insertion. With instantaneous metrics regarding the trajectory of the intracochlear electrode and the forces it
endures, the surgeon can make data-driven micro-adjustments that optimize electrode placement, minimize
structural damage, and improve the surgical outcomes for patients. The system integrates 3 primary
components: (i) a flexible micro-electromechanical systems (MEMS) strain sensor to detect changes in the CI
electrode, (ii) ML models to transform the raw strain into clinically relevant metrics, and (iii) hardware to collect
and process the data and display information to surgeons in real-time. This Phase II proposal builds on our
successful Phase I SBIR effort, which developed a benchtop prototype system, completed component-level
optimization, and demonstrated feasibility. The next major steps to allow system validation and successful
product introduction to the end-user (surgeon) are (1) Refinement & optimization of the CI sensor system and
validation of performance; (2) ML Sim2Real transfer for electrode state detection and clinical event detection;
and (3) a Powered cadaver study for validation and data collection with the integrated CI system. Aims 1 and 2
are parallel, yet synergistic: ML models will identify critical features of insertion; sensor design iterations will
detect these features; and the process will be repeated and re-evaluated. This will result in an optimized
hardware platform of a sensor-enabled CI electrode, featuring an optimized sensor design to provide detailed
real-time information on the electrode state paired with optimized ML models to interpret the raw strain data and
generate clinically relevant features. The final outcome of the validation study will be the demonstration of
reduced intracochlear trauma via histological analysis using the 5-point Eshraghi scale. The successful outcome
of this Phase II effort will result in the design freeze of the CI system and end user validation, producing a
translation-ready device in preparation for out-licensing and adoption by CI companies for real-world use.

Public health relevance
NARRATIVE Although cochlear implants are highly successful overall, structural damage following the procedure is common, degrading residual hearing and affecting patient outcomes. This project will develop and validate a novel surgeon guidance system using a sensor that can be integrated with existing cochlear implant electrode designs to detect bending and forces during implantation. The guidance system will provide the surgeon with real-time information to assist them to detect and avoid trauma during the procedure, allowing many more patients to regain their connection with the hearing world and enjoy a higher quality of life.